Core C: Computation and Software Development Core

Core C: Computation and Software Development Core
The overall goal of Core C is to provide researchers involved with the Program Project with
support and guidance for all their computational needs while developing their code, as well as
assistance with implementation of algorithms in the form of scientific software. As such, Core C
will play a central role in the success and impact of each of the research projects. We have
organized the Core activities into two main aims: High-Performance Computing [HPC] and
Scientific Code Development. In doing so, we are conscious of two key concepts: Reliability, and
Scalability.
Our first Specific Aim focuses on high-performance computing. The Core will be involved in
activities ranging from developing and allocating resources for computation, to actively reviewing
or developing new methods for dealing with data that may be both ‘big’ and complex. Specifically,
we will focus on the use of parallel computing, cloud computing technologies, and out-of-memory
data analysis techniques.
Our second Specific Aim focuses on scientific code development. Software tools are a corner-
stone component when it comes to the diffusion and wide-spread use of novel statistical methods.
The Core will assist members in developing the code for such software, with a special emphasis
on the efficient implementation of algorithms, based on two fundamental principles, reliability and
scalability. To this end, we will develop standards and guidelines on scientific software
development--including themes such as documentation, version control, continuous integration
and unit tests--to be followed by the project members. Furthermore, Core C will both advise and
actively participate in the implementation process of the methods developed by each project.
Ultimately, the Core will be involved throughout the process all the way from initial algorithmic
design and implementation of the methods, up to final software design, packaging and public
release.
Additionally, the Core will play a number of other key roles supporting the other Program Project
components. Examples of these include resource allocation, simulation of test data, and
development of computational-methods tutorials that can be distributed in partnership with the
educational efforts of Core D.

Public health relevance
Core C: Project Narrative Core C has the overall goal of providing researchers of the program project with support and guidance for all their computational needs. A consequence of our work implementing statistical methods developed by the project will be the design and creation of novel computational resources that enable those analyses. We anticipate that we will create numerous new libraries and software packages that will not only support our own developments but also serve the entire scientific community.